EXposomic Profiling in Airway disease to uNravel Determinants of disease in Asthma (EXPAND-Asthma) Center

Project Summary/Abstract
This supplement aims to support Sally Guan for two years prior to graduate school matriculation to help her
build a strong foundation grounded in mixed methods research and achieve her career goals of becoming a
scientific researcher who studies the intersections between climate change, environmental justice, and
community health. This research fellowship will provide Sally with an opportunity to develop the fundamental
skills to prepare her to conduct her own independent research. Under the guidance of Dr. Neeta Thakur, Sally
will estimate indoor infiltration of outdoor fine particulate matter (PM2.5) and will be investigating housing quality
as an important modifiable target for augmenting exposure to outdoor air pollution for children with asthma.
Sally will contribute to the EXposomic Profiling in Airway disease to uNravel Determinants of disease
(EXPAND) Asthma study. It is known that social stressors and environmental exposures are strongly
associated with asthma morbidity, and this relationship disproportionately affects communities of color. To best
understand this relationship, UCSF is working with LifeLong Jenkins Health Center to help recruit children and
adolescents, ages 8-16 years, with and without asthma to participate in the study. Sally’s role would be to
estimate the infiltration factor in the homes included in the EXPAND study. Participants in the study will have a
purple air monitor in the homes to capture spatial and temporal trends — specifically PM2.5. Sally will also use
a qualitative method to further understand the barriers to access to retrofits and weatherization for those
participating in the study.

Public health relevance
Project Narrative The supplement aims to support Sally for two years to help build a strong foundation in research before applying for graduate school. Under the mentorship and guidance of Dr. Neeta Thakur, Sally will contribute to the EXposomic Profiling in Airway disease to uNravel Determinants of disease (EXPAND) Asthma study that aims to explore how underrepresented children and adolescents with and without asthma respond to social exposures like poor air quality.